Genotyping the Understanding America Study to generate novel opportunities for research on cognitive functioning and dementia

Project summary / abstract
Cognitive impairment and dementia are prevalent and cause significant morbidity and substantial financial and
social burden. With the rising number of cases of dementia in the U.S. and worldwide, there is an urgent need
to identify opportunities for preventing or delaying its onset.
In this infrastructure proposal, we propose to make use of recent advances in genetics by genotyping the
Understanding America Study (UAS) and constructing “polygenic scores” (PGSs), indexes that aggregate the
small effects of millions of genetic variants from across the genome, for use in social-science studies of factors
that increase or mitigate the risk of Alzheimer’s Disease and Related Dementias (ADRD). The UAS, a probability-
based Internet panel housed at the Center for Economic and Social Research (CESR) at the University of
Southern California, longitudinally tracks a sample of approximately 10,000 adults in the U.S. (growing to at least
20,000 by 2026). It combines several sources of information, including from surveys, wearable devices,
administrative linkages, and contextual data, and has several unique features: it provides the opportunity for on-
demand data collection on short notice; it allows for the collection of data at higher frequencies and for the
possibility of initiating new data collection in response to major societal events (such as the COVID-19
pandemic), or triggered by events in the lives of respondents (such as “burst surveys” fielded when there is an
important change in the life of a panel member); it can be used to take advantage of natural experiments; it
allows for frequent collection (once or twice a month) of paradata (computer user-behavior from surveys, e.g.,
errors and processing speed gleaned from keystrokes) which is predictive of cognitive functioning.
Ours is not a genome-wide association study (GWAS). Instead, we will use genetic variants (SNPs) identified
from existing large, replicated GWASs, to create polygenic scores (PGSs), and exploit unique UAS capabilities,
afforded by its Internet mode of operation, to better understand ADRD risk in a nationally representative sample.
We will use PGSs, as well as APOE-ε4 status, together with longitudinal health, cognitive, behavioral, and
environmental measures, to: (i) identify populations at risk of cognitive decline, (ii) collect new data for causal
inferences of the effects of ADRD risk/protective factors on cognition by genetic ADRD risk, and iii) study the
role of genetics in the resilience to adverse life events affecting cognitive functioning.
By making publicly available a large number of genetic measures for ADRD, cognitive decline, and
associated protective/risk factors (e.g., physical activity, cardiovascular risk [diabetes, obesity, smoking and
hypertension], diet, sleep, pollution, and education, among others), and through our own research, we seek to
stimulate the use of unique UAS capabilities in economic and social-science research of ADRD, cognitive
impairment, and cognitive decline.

Public health relevance
Project narrative In this infrastructure proposal, we propose to genotype the Understanding America Study (UAS), a nationally representative Internet panel that longitudinally tracks a sample of about 10,000 (growing to at least 20,000 by 2026) adults in the U.S. We will create a large number of “polygenic scores” (PGSs), indexes that provide an aggregated measure of the genetic influences towards a specific trait. By making publicly available a large number of PGSs for ADRD and cognitive decline, in combination with associated protective and detrimental health, environmental, and behavioral factors, and through our research, we aim to stimulate creative social- science research in ADRD, cognitive impairment, and cognitive decline that utilizes the unique capabilities of the UAS.